PREVENTING ALZHEIMER’S DISEASE-LIKE BRAIN PATHOLOGY IN HIV INFECTION BY TARGETING CCR5

PROJECT ABSTRACT
Brain tissues from people living with HIV (PLWH) showed evidence of Alzheimer’s Disease (AD)-like pathologies,
including increased neurotoxic amyloid-b (Ab40/42), amyloid plaques and Tau hyperphosphorylation (pTau)
associated with neurodegeneration and HIV-associated neurocognitive disorders (HAND). The mechanisms
through which HIV increase Ab, pTau, and induce AD-like central nervous system (CNS) impairment are not
known. Although most PLWH with CNS Ab plaques and pTau had been on long-term antiretroviral therapy (ART),
the role of ART in pTau and Ab production, and AD-like pathologies has not been investigated. Findings from
our R21 studies, using in vitro, in vivo and ex vivo approaches, demonstrated that HIV-1 significantly increased
CNS Ab42 and pTau in humanized mice, and this was associated with significantly 1) increased expression and
activation/activity of b-secretase-1 (BACE1), soluble (s)APPb (amyloidogenic pathway effectors), and GSK3b
(kinase that phosphorylates Tau); 2) reduced expression/activity of neprilysin (NEP, Ab-degrading enzyme); 3)
increased blood-brain barrier (BBB) expression of the receptor for advanced glycation end products (RAGE,
mediates Ab CNS influx), and reduced BBB expression of low-density lipoprotein receptor–related protein-1
(LRP1, mediates CNS Ab efflux); and 4) increased neuroinflammation, neuronal damage and BBB injury. We
demonstrated that LRP1 and CCR5 mediated Ab transport through the BBB, that AZT potentiated HIV-induced
upregulation/activation of BACE1, sAPPb and GSK3b, and that AZT blocked NEP expression/activity.
Significantly, the CCR5 antagonist maraviroc (MVC) abrogated these HIV- and AZT- induced effects.
Thus, we hypothesize that CCR5, via LRP1, plays a major role in Ab formation, transport, and catabolism,
amyloidogenesis and pTau in PLWH, and that targeting CCR5 prevents HIV-induced Ab and pTau,
increases Ab CNS efflux, and abrogates CNS injury and HAND. Using a validated HIV/AIDS animal model,
primary human cells and human brain tissues, we will test this hypothesis and further investigate the effects of
commonly prescribed antiretroviral (ARV) drugs (AZT, TDF) on HIV-induced activation of BACE1 and APP
amyloidogenic pathway, Tau metabolism, and CNS injury (Aim-1); Ab transport, degradation, clearance, and
neuroinflammation (Aim-2); and associated BBB transcriptomic and epigenomic signatures (Aim-3). These
mechanistic studies will help determine whether HIV induces amyloidogenesis by i) activating BACE1 pathways
to increase Ab production or ii) by interfering with LRP1-mediated Ab transport, degradation, clearance; iii) the
role of ARVs; iv) whether CCR5 modulates these effects; and v) characterize the brain vascular transcriptome
and epigenome associated with HIV/ARVs-induced dysregulation and MVC protective effects. Our proposed
studies are of high-impact, translational significance, and address the NIH high priority research areas that focus
on “Examining the pathophysiologic mechanisms of HIV-induced CNS dysfunction in the setting of ART…and
development of novel therapeutic approaches to mitigate CNS complications of HIV infection.”

Public health relevance
PROJECT NARRATIVE People living with HIV that develop HIV-associated neurocognitive impairment (HAND) show increased brain amyloid-β (Aβ) production and aggregation, amyloid plaques, increased Tau hyperphosphorylation (pTau) and formation of neurofibrillary tangles-like structures, but the associated mechanisms are not known. This proposal will investigate the role of CCR5 in these pathologies and determine whether following HIV-1 infection, co- administration of antiretroviral drugs with the CCR5 antagonist maraviroc can prevent the formation of amyloid plaques, pTau, and neuroinflammation, abrogate brain vascular injury, neuronal loss and HAND. These novel studies involve mechanistic in vitro, in vivo, and ex vivo approaches and are relevant for designing therapeutic strategies to prevent or reduce Alzheimer’s Disease-like pathologies in HIV-infected individuals.